ISLET CELL AUTOANTIBODIES AND THE NATURAL HISTORY OF INSULIN DEPENDENT DIABETES

The primary purposes of this protocol are to develop strategies to identify individuals prior to the onset of insulin dependent diabetes and to understand its history and pathogenesis.